2023 Mycotoxins and Phycotoxins Gordon Research Conference and Seminar

Summary
The 2023 Gordon Research Conference (GRC) on Mycotoxins and Phycotoxins - Emerging impacts and
challenges of biotoxins on environmental and human health, provides an international forum for the
presentation and discussion of emerging research on fungal, algal, and cyanobacterial toxins, their effects on
human and ecosystem health, and the biology and ecology of the organisms that produce them. Fungal, algal,
and cyanobacterial toxins are naturally occurring food and water contaminants that adversely affect human and
animal health. A multidisciplinary approach is critical in detecting, understanding, managing and mitigating their
health and economic impacts. The 2023 Gordon Research Conference on Mycotoxins and Phycotoxins will
provide a forum for academic, government, and private sector scientists to exchange ideas on harnessing
advances in biology, chemistry, ecology, plant pathology, epidemiology, and risk assessment to address the
problems associated with the occurrence of those natural toxins. The goal of the conference is to bring
together a wide range of outstanding senior scientists, young investigators, and students to address the task of
ensuring the safety of food and water supplies. Interactions between junior and senior scientists will be strongly
promoted in the best tradition of Gordon Research conferences and contribute to the evolution of new
strategies for dealing with the complex problems presented by naturally occurring toxins. Vigorous discussions
guided by discussion leaders recognized for their expertise in each particular area will be key for the
conference. Dedicated daily poster sessions will provide an opportunity for fertile cross-disciplinary interactions
and ample time is foreseen for that.
The Gordon Research Seminar, immediately preceding the GRC, will be organized and conducted by graduate
students and postdoctoral scientists from the many disciplines involved in advancing mycotoxin and phycotoxin
research. Junior scientists will present their work in a formal, oral format and engage in discussion with their
peers. The environment will be welcoming and collegial and will provide an unmatched opportunity for future
researchers to interact with established scientists. Two leading students from this seminar will additionally
present within the GRS.

Public health relevance
Project Narrative Fungal toxins (mycotoxins), algal and cyanobacterial toxins (phycotoxins) are major sources of food-borne and water-borne intoxications to humans, agricultural animals, domestic pets and wildlife. Safeguarding the public requires an understanding of their sources (especially increasing prevalence in the environment), and their chemistry and toxicology. The Gordon Research Conference on Mycotoxins and Phycotoxins provides an international, interdisciplinary forum for the discussion of emerging research on these toxins.